Caring for Providers to Improve Patient Experience (CPIPE) Study

PROJECT SUMMARY:
An estimated 800 pregnancy-related deaths occur daily. Most of these deaths occur in low- and middle-income
countries (LMICs), with about two-thirds in sub-Saharan Africa (SSA) alone. Skilled care in health facilities is
critical to improving maternal and neonatal outcomes. Yet, only about two-thirds of births in SSA occur in
health facilities—with wide disparities, especially by socioeconomic status (SES). Poor person-centered
maternal care (PCMC) is a key driver of both the low rates of facility-based deliveries and disparities. Further,
where facility-based childbirth rates have increased, poor PCMC leads to morbidity and mortality due to
delayed, inadequate, unnecessary, or harmful care. Yet, there is limited research on interventions to improve
PCMC in LMICs; and existing interventions do not explicitly address inequities in PCMC experiences. To
address this gap, we designed the “Caring for Providers to Improve Patient Experience” (CPIPE) intervention
to address drivers of poor PCMC and center the unique needs of vulnerable women in LMICs. CPIPE is a
theory and evidence-based intervention with 5 components: provider training, peer support, mentorship,
embedded champions, and leadership engagement. The training is a simulation-based curriculum that
integrates content on PCMC, stress, burnout, and bias into emergency obstetric and neonatal care drills. We
target provider stress and bias because they are mutually reenforcing factors driving poor and inequitable
PCMC. The other intervention components create an enabling environment for behavior change. Our pilot
studies show high feasibility, acceptability, and preliminary effectiveness. We therefore propose a cluster
randomized-controlled trial, in 40 high-volume delivery health facilities in Kenya and Ghana, to assess the
impact of CPIPE on PCMC and intermediate and distal outcomes in our conceptual model. We will accomplish
this through 3 aims. Aim 1: to assess the effectiveness of the CPIPE intervention on PCMC in Kenya and
Ghana. We hypothesize that CPIPE will improve PCMC for all women, and especially for low SES women. Our
primary outcome is PCMC measured with the PCMC scale through multiple cross-sectional surveys of mothers
who gave birth in the preceding 9 weeks in study facilities at baseline (prior to intervention), midline (6 months
post-baseline), and endline (12 months post-baseline) (N=2000 at each time point). A sub-aim 1 will assess
the cost-effectiveness of CPIPE. Aim 2: to examine the mechanisms of impact of CPIPE on PCMC. We will
assess the effect of CPIPE on intermediate outcomes such as provider knowledge, self-efficacy, stress,
burnout, and bias levels; and conduct mediation analysis to assess if changes in these outcomes account for
the effect of CPIPE on PCMC. Aim 3: to assess impact of the CPIPE intervention on distal outcomes including
maternal health seeking behavior and maternal and neonatal health; and examine if changes in PCMC account
for these effects.

Public health relevance
NARRATIVE: Poor person-centered maternal care (PCMC) contributes to high maternal mortality and morbidity, directly and indirectly, through lack of, delayed, inadequate, unnecessary, or harmful care. The proposed R01 will test the effectiveness of an intervention that targets provider stress and bias to improve PCMC. The results will advance the evidence base for interventions to improve PCMC and contribute to equity in maternal and neonatal health.